Gait as a Preclinical Marker for Alzheimer's Disease and Dementia: insights from super-movers, usual-movers, and slow-movers

Emerging research implicates gait dysfunction as a preclinical marker of Alzheimer’s disease and related
dementias. Our team has been in the vanguard of gait and cognition research. To advance the field, we will
employ innovative gait phenotyping and multidisciplinary team science approaches to discover novel risk and
protective mechanisms for gait dysfunction in the context of dementias. The aging population can be classified
into slow-movers (1SD below ‘robust’ mean speed for age and sex), usual-movers ( 1SD) and fast-movers
(≥1SD). We will employ novel multi-modal neuroscience, neurophysiological, and biological approaches to
discover novel risk mechanisms in the earliest stages of gait and cognitive decline (preceding slow mover stage).
We introduce the original concept of ‘super-movers’: non-demented and non-disabled fast movers, 80 years
and older with gait speed of adults 30 years younger. We posit that this unique group of oldest fast movers are
enriched in unique brain and biological profiles that help maintain exceptional gait into their 9th decade, and will
provide a window into protective mechanisms. We hypothesize that the interplay between pathological and
resilience mechanisms in aging results in structural, functional, and neurophysiological brain changes leading to
the emergence of gait dysfunction as a preclinical marker of dementia.
Aim 1: Identify protective brain mechanisms linked to gait in super-movers. We predict that compared to
usual movers (≥80y): 1A: Super-movers will have better brain health on multi-modal measures. 1B: Super-
movers will show differential activation over premotor and sensorimotor cortex sustained across the gait cycle in
response to complex gait demands. 1C: As some (but not all) fast-movers will age into super-movers, we will
compare neuroimaging and mobile EEG measures in fast-movers vs usual/slow movers in all participants (≥65y).
Aim 2. Establish neurophysiological mechanisms underlying gait and cognitive decline in aging. In the
overall sample (≥65y): 2A: Baseline gait related mobile EEG activation patterns will predict longitudinal declines
in cognition as well as combined cognitive-motor decline. 2B: Poor multisensory integration at baseline will
predict longitudinal declines in cognition and Motoric Cognitive Risk syndrome.
Aim 3. Determine pathological mechanisms underlying gait and cognitive decline in aging. We predict
among adults ≥65y: 3A: Slow movers will have more, and faster movers will have less neurodegenerative
pathology (p-Tau, Aß-42 and NFL) than usual movers. 3B: Higher levels of neurodegenerative pathology at
baseline will predict cognitive decline and Motoric Cognitive Risk syndrome.
This proposal is highly responsive to RFA-AG-24-041. Successfully attaining our aims will inform the use of gait
as an early ‘cognitive’ biomarker, identify protective mechanisms that promote resilience to Alzheimer’s disease
and related dementias, and guide the design of early interventions to prevent cognitive decline.

Public health relevance
Narrative Emerging research implicates gait dysfunction as a preclinical marker of Alzheimer’s disease (AD) and related dementias (ADRD). Building on our research, we will employ a team science approach with multi-modal neuroscience and biological methods to examine mechanisms underlying gait and cognitive decline in aging. Our overall hypothesis is that the interplay between pathological and resilience mechanisms in aging results in structural, functional, and neurophysiological brain changes that lead to the emergence of gait dysfunction as a preclinical marker of dementia.